Center for Biomedical and Brain Imaging (CBBI)

Center for Biomedical and Brain Imaging (CBBI)
Summary
The major objective of the Center for Biomedical and Brain Imaging (CBBI)
Core is to provide support and educational opportunities to neuroscientists in Delaware
who are investigating structure-function-behavior relationships in the brain, and help
them develop new neuroimaging approaches that will advance their research and careers.
By combining animal and human neuroimaging, our CBBI Core serves a second objective of bringing together
biologists, psychologists, biomedical engineers and others who image the human brain, with molecular, cellular and
behavioral neuroscientists who use animal models, to catalyze collaborations focusing on multi-scale investigations of
functional activity in the brain. The University of Delaware (UD) has made a significant investment into building
capabilities for human and animal neuroimaging- purchasing a 3T MRI scanner with the capability to map human brain
structure and function, and with partial support from our Phase II COBRE, a 9.4T, small bore scanner for high
resolution mapping of the structure and function of brains in rodent models.
Our CBBI core will support investigators utilizing non-invasive neuroimaging techniques by providing access
to collaborators and consulting expertise to help develop innovative projects that can form the basis for competitive,
interdisciplinary grant applications. Our objective for this aim is to increase the number of neuroscience investigators
at DSU, UD and across the state who have research project grant funding from NIH. Currently our CBBI core has
contributed to active R01 awards to six faculty and R21 awards for 8 faculty. Our objective is to double those numbers
to 12 faculty with R01 awards and 16 with R21 awards. Our Phase III COBRE award will support a program of Core
Access Awards to allow Delaware researchers to collect pilot neuroimaging data to support publications and grant
applications. Currently there are 35 faculty PIs using the CBBI Core, and we expect that our Core Access Award
program will grow that number 50% to over 50 by the end of our Phase III award.
The unifying focus of the Delaware Center for Neuroscience Research is investigating how the dynamic
structures of the brain are changed over the lifespan by experiences, the environment and genetics. Our Biomedical
and Brain Imaging Core provides crucial support for neuroscientists affiliated with the Delaware Center for
Neuroscience Research to reach their full scientific and professional potential - including attaining grant support for
their research. It also creates an environment that helps attract outstanding neuroscience researchers to fill new
positions, at both DSU and UD, while advancing the research of a broader community of neuroscientists already in
Delaware

Public health relevance
Delaware Center for Neuroscience Research Public Health Relevance Summary The foundation of Phase III proposal is Delaware’s expanding set of human and research resources in neuroscience, which has Delaware neuroscience research competitive on a national level. Our project supports research aimed at determining how thoughts, memories, feelings and actions emerge from dynamic activities in the brain and are changed over time; as well educational programs to develop a workforce that can participate in and benefit from advances in our understanding of brain function. An increased understanding of how the brain and nervous system functions will facilitate treatments for diseases and injuries and provide insights into human behavior, biases, and cognition.